Adapting and testing a behavioral intervention to prevent FASD and adverse infant outcomes

This R61/R33 application proposes to adapt and test an evidence-based behavioral intervention to decrease
polysubstance use (i.e., alcohol and tobacco/cannabis) during pregnancy and lactation and prevent adverse
clinical outcomes, including fetal alcohol spectrum disorder (FASD) in South Africa (SA). SA has a long
history of social and health disparities, resulting in the world's highest rate of FASD (111.1 per 1,000), where
lifelong negative cognitive and physical effects result from prenatal alcohol exposure. FASD is completely
preventable if women do not drink during pregnancy. Prenatal alcohol use frequently co-occurs with other
substance use, especially tobacco and cannabis. The adverse effect on birth outcomes by alcohol and
tobacco use together is worse than either substance alone. Recent evidence from animal models shows that
prenatal exposure to both cannabinoids and alcohol potentiate the likelihood of alcohol-induced birth defects.
Data from Cape Metropole, SA, showed that all women who reported prenatal alcohol use also tested
positive for tobacco use, with 25% also reporting cannabis use. Alcohol use while breastfeeding also occurs
at a relatively high rate in SA. Despite tremendous health benefits from breastfeeding, maternal alcohol use
while breastfeeding significantly compromises infant development. Contingency management (CM) has been
efficacious in reducing prenatal cocaine, alcohol, and tobacco use in the United States (U.S.). The Women's
Health CoOp (WHC) is an evidence-based brief intervention addressing women-focused syndemic issues
and resulting disparities associated with substance and alcohol use. These evidence-based interventions
need to be combined and adapted for addressing maternal polysubstance use and associated health and
behavioral issues during pregnancy and lactation in SA. The Specific Aims are as follows: (1) R61 Aim 1—
Conduct formative qualitative research with women who are pregnant or breastfeeding with a recent history
of polysubstance use, clinic and community stakeholders, and an established Community Collaborative
Board. (2) R61 Aim 2—Test feasibility, acceptability, and appropriateness of the adapted intervention with
48 women (24 pregnant and 24 breastfeeding) in Cape Metropole, SA. (3) R33 Aim 1—Examine the
effectiveness of the adapted intervention (i.e., CM and text-based support with WHC educational
components) in a 2-group randomized controlled trial with 184 women who are pregnant and follow up
during pregnancy and 3 months postpartum. (4) R33 Aim 2—Examine the impact on gestational, birth, and
infant outcomes. (5) R33 Aim 3—Track cost and conduct preliminary cost-effectiveness analyses.

Public health relevance
PROJECT NARRATIVE The study proposes to adapt and test an evidence-based behavioral intervention to decrease polysubstance use (i.e., alcohol and tobacco/cannabis) during pregnancy and lactation and prevent adverse clinical outcomes, including fetal alcohol spectrum disorders in South Africa. The project is relevant to public health: (1) the proposed research addresses the research goals of the National Institute on Alcohol Abuse and Alcoholism by addressing maternal alcohol and combined substance use during pregnancy and lactation and prevention of fetal alcohol spectrum disorders and adverse infant outcomes globally; (2) the proposed research investigates health disparities on maternal polysubstance use and other related issues globally; and (3) the proposed research has potential to lead to larger scale effectiveness and implementation studies in South Africa, the United States, and globally, which will set the stage for implementing a sustainable intervention and developing comprehensive policy recommendations on maternal polysubstance use in South Africa, the United States, and other countries.